PULSATILE GONADOTROPIN RELEASE IN WOMEN WITH POLYCYSTIC OVARY SYNDROME

This study will address the issue of characterizing the pulsatile secretion of immunoactive LH and FSH and bioactive LH in women with polycystic ovary syndrome by using state-of-the-art pulse analysis techniques. COMPUTER ONLY.